Prenatal behavioral intervention to prevent maternal cytomegalovirus in pregnancy

The long-term goal of this research is to reduce congenital cytomegalovirus (cCMV) infections by an efficacious
prenatal CMV risk-reduction intervention that reduces maternal CMV infections during pregnancy, thereby
reducing damaging congenital CMV infection. The study will evaluate the efficacy of our previously successful
brief prenatal clinic-based, theory guided CMV risk-reduction behavioral intervention to prevent maternal CMV
infections during pregnancy in young high risk women who have frequent CMV exposures and whose infants
are at increased risk of congenital CMV infections. Young pregnant women will be recruited into a CMV cognitive-
behavioral intervention trial following their first prenatal visit. After enrollment, they will be randomized to either
the CMV risk-reduction intervention or an attention-matched control stress-reduction intervention stratified by
their CMV serostatus. Women in both groups will attend an individualized behavioral skills session, watch a short
video, receive a take home packet, receive weekly text/email messages for 12 weeks that reinforce the
experimental and control interventions, and attend follow up visits at 6 and 12 weeks. Saliva, urine, vaginal, and
blood specimens will be collected at enrollment and at follow up visits. Additionally, at home saliva and vaginal
specimen collection will occur at 3 and 9 weeks, and also once during the third trimester of pregnancy. At
delivery, a saliva specimen will be collected from both the mother and infant, along with a remnant cord blood
specimen. The primary study outcomes include: reduction of primary infections in CMV seronegative women
and reduction of reinfections in CMV seroimmune women who are randomized to the CMV risk-reduction
intervention. Secondary endpoints are 1) the reduction of CMV risk behaviors and increased protective behaviors
indicated by self-report on questionnaires; 2) proportion of infants with cCMV confirmed in the first 21 days of
life; 3) CMV shedding and CMV viral load indicated by CMV DNA by PCR in saliva, urine, vaginal, or blood
specimens; 4) new CMV variants; 5) anxiety/stress levels measured by psychosocial scales; 6) measures of
adherence and acceptability of the intervention; 7) changes in CMV knowledge indicated by questionnaires; and
8) risk factors for maternal CMV infections during pregnancy (age, race/ethnicity, exposures/behaviors related
to young children, sexual activity indices). Outcomes will be assessed through pre- and post-intervention CMV
risk behaviors questionnaires in both intervention groups. Possible CMV exposures will be assessed by
questionnaires at each visit and by prenatal medical records that will be obtained for all women. CMV primary
infections, CMV reinfections, and CMV viral shedding and viral load will be assessed by IgG, IgM, and avidity
assays, serologic strain-specific assays, next generation sequencing of viral DNA, and PCR assays for women
in both intervention groups. The outcomes of this randomized controlled trial will inform prenatal health care
decisions by providing evidence that prenatal CMV risk-reduction counseling for pregnant women can reduce
maternal CMV infections, and thereby also lower the rate of cCMV infection in their offspring.

Public health relevance
Cytomegalovirus (CMV) can be transmitted from mother to fetus causing significant disabilities. It is important to find strategies that will either prevent or lessen the risk of virus acquisition for women, thus reducing the risk of damaging congenital CMV infection in their infants. The proposed project seeks to prevent maternal CMV infections by increasing CMV risk-reduction behaviors in urban pregnant women.